Mechanisms of oligodendroglial ciliary function in white matter injury repair

PROJECT ABSTRACT
After damage to white matter tracts (WMI) in CNS diseases such as multiple sclerosis (MS) in adults and
newborn brain injuries that cause cerebral palsy (CP), myelin sheaths can be regenerated by activated
oligodendrocyte precursor cells (OPCs). Failure of this remyelination program often occurs due to the improper
recruitment of OPCs into injury sites, contributing significantly to ongoing neurological dysfunction and disease
progression. Understanding the mechanisms controlling OPC biology during remyelination will provide insights
as to why myelin repair fails in human cases. Importantly, OPCs dynamically produce primary cilia, microtubule-
based organelles that transduce intercellular cues in a specialized signaling compartment. The role of primary
cilia in regulating developmental pathways in OPCs remains poorly understood. Here, we show that OPCs
require primary cilia to respond properly to WMI. First, this grant will demonstrate that genetically removing
primary cilia from OPCs results in inadequate WMI repair, identifying the primary cilium as a critical
effector of biological change in OPCs necessary for the WMI response. Furthermore, as there remains little
mechanistic understanding of ciliary signaling pathways in OPCs, we will use a combination of approaches that
ultimately define a GPCR/cAMP/CREB signaling axis beginning at the primary cilium as a crucial regulator
of OPC biology. Finally, with recent advances in proximity-labeling, we can now catalogue the proteins that
survey OPC primary cilia using a technique termed cilia-APEX. This grant will utilize cilia-APEX to identify
signaling molecules that localize to OPC primary cilia in vitro and during remyelination in vivo. This will
demonstrate dynamic changes in the protein content of OPC primary cilia during different stages of
remyelination, while also adding significant insight into the extent of ciliary functions in OPCs. Together, these
studies will show that primary cilia are a critical signaling module in OPCs for the regulation of remyelination,
and will reveal potential therapeutic target for conditions such as MS and CP, where the OPC response to injury
can be dysfunctional.
1

Public health relevance
PROJECT NARRATIVE Myelin regeneration often fails in Multiple Sclerosis (MS) and human neonatal hypoxic injury leading to Cerebral Palsy (CP), and contributes significantly to ongoing neurological dysfunction and disease progression. Here we identify primary cilia as a critical new signaling module that controls the oligodendrocyte progenitor cell (OPC) response to white matter injury, identify how the cilium controls OPC behavior and the ciliary controlled signaling mechanisms within OPCs, and map the proteome of OPC primary cilia during development and remyelination in vivo. This grant will show that primary cilia signaling is a key effector of biological change in OPCs, and will identify potential therapeutic targets for debilitating conditions such as MS and CP, where white matter injury repair can be dysfunctional.